MicroRNA 34/449 family plays a critical role in choroid plexus differentiation and tumorigenesis

PROJECT SUMMARY/ABSTRACT
Tumors of the choroid plexus (CP) are rare primary brain neoplasms mostly found in children, accounting for up
to 20% of brain tumors that occur in the first year of life. CP papilloma (CPP) is typically benign and can be
resolved through surgery, but CP carcinoma (CPC) is a particularly aggressive brain cancer. CPC most
commonly arises in young children when they are unsuitable for radiation. Despite treatments that include
surgery, chemotherapy, and radiation, CPC usually responds poorly. CPC is prone to recurrence and metastasis,
with less than 50% of children still alive five years after diagnosis. In addition, survivors often suffer from
debilitating long-term treatment effects, including intellectual disability and increased cancer risk. The
development of safer and more effective therapies for CPC requires a better understanding of its biology. In this
application, accurate experimental models will be used to gain crucial insights into CP differentiation and
tumorigenesis, and facilitate the development of novel therapeutic strategies. Human CPCs frequently exhibit
mutation of TP53 tumor suppressor and abnormal NOTCH pathway activities. In mice, sustained NOTCH1
expression, or combined inactivation of Rb1 and Trp53 tumor suppressors led to aggressive CP tumor with
characteristics of CPC in humans. Multiciliated cells (MCCs) are present in the CP in humans and mice. MCCs
in the CP epithelium arise during embryogenesis and are mostly immotile. In contrast, CPCs in humans exhibit
solitary cilia, and disturbances to multiciliation program directed by GMNC, a transcriptional regulator of MCC
fate in diverse tissues including the CP. Accordingly, NOTCH-driven and Rb1/Trp53-deficient CPC display
singular cilia consequent to defects in multiciliation program, suggesting tumor suppression by GMNC
multiciliation program. Therefore, the impairment of the multiciliation program enables tumor cell proliferation.
Knowledge of GMNC program regulation may facilitate the promotion of multiciliation as a potential therapeutic
strategy in CPC. The project will focus on the interactions between the MCC differentiation program and
microRNA (miRNA) during CP development and tumorigenesis. Aim 1 will examine whether gene regulation by
miRNAs influences multiciliation in the CP. Both in vivo and in vitro studies will be conducted to investigate their
role and underlying mechanisms in MCC differentiation in the CP. A novel organoid model will be utilized to
characterize miRNA expression during multiciliation in the CP in humans. Transcriptomics studies will be
conducted to identify differentially expressed genes and potential miRNA targets in the CP. Though most CPC
in humans carry mutations in TP53 tumor suppressor that are associated with increased genomic instability and
poor prognosis, molecular mechanisms of TP53-deficient CPC remain poorly understood. Aim 2 will investigate
whether gene regulation by miRNAs influences multiciliation in TP53-deficient CPC. Both gain- and loss-of-
function studies will be conducted to investigate their role in CPC development. These studies will uncover post-
transcriptional mechanisms of CP differentiation and tumorigenesis.

Public health relevance
PROJECT NARRATIVE Knowledge of the biology of choroid plexus carcinoma (CPC) is critical for the development of innovative therapeutic strategies. The project will characterize the role of non-coding small RNAs in the differentiation of choroid plexus and CPC development. The project will utilize novel human organoid model to investigate the development and functions of choroid plexus.